Placental Ischemia, Hypertension and Hemodyanmics

Cerebral vascular changes play a significant role in the pathogenesis of preeclampsia with cerebrovascular events contributing to ~40% of all preeclampsia/eclampsia deaths. Little is understood about the underlying causative mechanisms. Several studies suggest that impaired cerebral blood flow (CBF) autoregulation during pregnancy/preeclampsia is a major underlying factor. We have compelling data that the ischemic placenta releases factors into the circulation that can impact cerebral vascular function. These factors include the cytokine tumor necrosis factor alpha (TNF-α), an activating angiotensin receptor type 1 autoantibody (AT1- aa), and an increase in soluble fms like tyrosine kinase (sFlt1) that impairs the function of proangiogenic factors like placental growth factor (PlGF). Importantly, these factors mirror changes that occur in human preeclampsia and are also observed in our experimental rat model of placental ischemia that mimics the characteristics of preeclampsia. This grant proposes that TNF-α can impair cerebral vascular tone and cerebral blood flow autoregulation by regulating intracellular vascular smooth muscle calcium ([Ca2+ ]IC). TNF-α also stimulates the production of the AT1-aa which is proposed to impair cerebral vascular function through and angiotensin receptor mediated mechanism. Finally, evidence in the literature shows that either the AT1- aa or TNF-α can promote an increase in circulating sFlt1 in this model of placental ischemia. sFlt1 has been shown to increase vascular permeability in the brain, and exogenous administration of the PlGF has been shown to attenuate hypertension in both rodent and nonhuman primate models of preeclampsia. This proposal will utilize the rat model of placental ischemia to test the central hypothesis that cerebral complications of preeclampsia are caused by the release of factors from the ischemic placenta (TNF-α, AT1aa, sFlt1) that directly impair cerebral vascular tone and blood flow autoregulation. We further hypothesize that these factors increase BBB permeability, which together with impaired CBF autoregulation leads to cerebral edema. This hypothesis will be tested in the following aims: (1) To test the hypothesis that circulating TNF-α production impairs CBF autoregulation by reducing cerebral vascular tone. (2). To test the hypothesis that the AT1-aa promotes impaired CBF autoregulation during pregnancy through an AT1 receptor mediated mechanism and directly increases BBB permeability. (3) To test the hypothesis that increased circulating sFlt1 caused by placental ischemia contributes to cerebral edema by increasing blood brain barrier permeability.

Public health relevance
Preeclampsia is a common pregnancy specific disease that is characterized by high blood pressure, kidney injury, and blood vessel damage. The brain blood vessels are commonly affected during preeclampsia and contribute to 40% of the deaths associated with this disease. This proposal will explore the reasons that cause brain blood vessel changes during preeclampsia.